Regulation of Protein C Pathways

Project Summary/Abstract
Activated protein C (APC) is a naturally occurring plasma serine protease that has been translated to the clinic
as a recombinant wild type or mutant biologic. In a diverse collection of preclinical animal injury models,
pharmacologic APC’s provides many benefits. APC and the protein C systems contribute to the regulation of
thromboinflammation that is critical for host defense, including defense versus SARS-CoV-2 infection. APC can
act on diverse cell types, including immune cells for suppression of graft-versus-host disease. APC not only has
anticoagulant activity but also initiates cell signaling via multiple receptors, in particular, via several protease
activated receptors (PAR). APC-initiated cell signaling contributes to tissue homeostasis and host defense
systems. Beneficial APC-initiated biased signaling is caused by specific cleavages of PAR1 and PAR3, and for
some critical biologic activities, e.g., reducing mortality in sepsis, APC requires the integrin, Mac-1. Despite
recent insights, there is a major gap in knowledge about protein-protein interactions between APC and its cellular
receptors. Aim 1 studies will use a very extensive library of > five dozen recombinant APC mutants to provide a
database regarding APC’s receptor specificities which will then enable engineering of APC mutants with
receptor-specific selectivity, e.g., an APC mutant with highly selective PAR1-specific or PAR3-specific signaling
capabilities or selectively specific for the I-domain of Mac-1. Such receptor-selective APC mutants will be useful
reagents for deciphering which receptors play critical roles on cells in vitro or in animals in vivo, and they may
lead to translation for novel APC mutants. To address the major problem of COVID-19, Aim 2 studies will
characterize how murine COVID-19-like symptoms in SARS-CoV-2 infected hACE2 mice are influenced by
endogenous protein C systems, e.g., by anticoagulant systems, by cytoprotective systems including anti-
inflammation, anti-apoptosis, and endothelial barrier stabilization, and by fibrinolysis systems. Studies will define
how these systems are modulated to be either hyperactive or hypoactive. This will provide new insights into how
the protein C systems may be intertwined with defense versus SARS-CoV-2. The most promising cytoprotective-
selective APC mutant (3K3A-APC) will be tested for COVID-19 therapy to advance potential translation. Aim 3
will characterize the multifaceted roles of APC in the pathobiology of acute traumatic coagulopathy. Studies will
assess mechanisms by which disproportional APC generation contributes either to the development of acute
traumatic coagulopathy involving Factor V inactivation and hyperfibrinolysis or, conversely, to protection of the
integrity of organ function during and after acute traumatic coagulopathy by way of APC’s cytoprotective
activities. The proposed studies will provide novel mechanistic insights and new APC variants which may aid
translations to the clinic related to the APC pathways.

Public health relevance
Project Narrative This project is focused on obtaining basic knowledge about protein-protein interactions that are responsible for the beneficial, protective activities of the enzyme, activated protein C, which can provide multiple activities that reduce damage to cells and tissue. Based on preclinical studies in animals, activated protein C shows beneficial, often mortality reducing effects in the settings of ischemia/reperfusion injury of the heart, kidney and lungs, ischemic stroke, graft vs. host disease, kidney transplant, inflammatory lung injury, gastrointestinal inflammatory diseases, pseudomonas lung infection, acute neurotrauma, pancreatic islet transplantation, diabetes, and severe whole-body radiation. Thus, new knowledge about activated protein C variants may lead to improved 2nd or 3rd generation biologics for man.